A Family Centered Approach to Intimate Partner Violence

PROJECT SUMMARY
Intimate partner violence (IPV) among caregivers is an important risk factor for the physical abuse of children.
IPV affects 1 in 4 American women, with children present during almost half of the episodes of IPV. IPV may
serve as a “sentinel” event and can provide an opportunity for both early detection and secondary prevention of
abuse in a child who lives in an affected household. Physical abuse affects about 120,000 children annually in
the US, with the youngest children (<3 years old), who are usually unable to provide a history, at the highest risk.
Physical child abuse occurs in 30-60% of homes with IPV. We have shown that occult or inapparent injuries are
often detected by x-rays when young children living with IPV undergo evaluation for abuse. Yet, most children
who live with recognized IPV are not evaluated, perhaps because the care of abused children and adults is
separated into different, often competing care systems. Family-Centered Care (FCC), a process in which the
needs of children and caregivers are considered together, may improve caregiver engagement with the
evaluation of children for physical abuse and with IPV-related services.
The objective of the proposed research is to develop and evaluate an FCC model to improve evaluations for
physical abuse of IPV-exposed children and to engage the IPV victim in attending to her own needs. First, we will
conduct qualitative interviews of local stakeholders (including victims of IPV) and national leaders and will observe
the current process of evaluating IPV-exposed children by child protective services and by medical providers to
identify barriers to and facilitators of these evaluations. Using these data, we will use a systematic decision-
making process to develop an FCC model to improve the medical evaluation of IPV-exposed children and an
implementation strategy to enhance its use. A successful FCC model might link the child’s medical visit with
providing an advocate to connect the abused caregiver with IPV services based on preliminary data. Finally, we
will conduct a pilot trial in which we will compare our model of FCC with usual care for its acceptability and the
feasibility of subsequent studies of its efficacy. Our central hypothesis is that an FCC model that simultaneously
addresses the needs of children and caregivers will improve caregiver engagement, improve recognition of child
abuse, and reduce the risk of subsequent IPV.
I will also pursue formal training to acquire advanced skills and knowledge in community-engaged research, the
practical application of implementation science, the conduct and evaluation of clinical trials, and the development
of independent research grants. My mentors are experts in clinical and community-engaged research, child abuse
pediatrics, familyviolence, and implementation science with extensive experience mentoring junior faculty. In
addition to guidance on career development, they will provide hands-on mentorship for the proposed studies.
They will ensure that I achieve my long-term goal of becoming an independent investigator who improves child
abuse detection and identifies best practices to strengthen FCC for IPV.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV) affects 1 in 4 American women, and surveys of victims suggest that physical child abuse occurs in 30-60% of homes with IPV, but these data have not resulted in the routine evaluation of physical abuse in children exposed to IPV. IPV may serve as a “sentinel” event and may provide an opportunity for early recognition and secondary prevention of physical abuse in a child who is exposed to IPV. In this study, we will identify barriers to and facilitators of the screening of IPV-exposed children who have been reported to a local child protective services agency for exposure to IPV, perform intervention mapping to develop and implement a Family-Centered Care (FCC) model for children and caregivers living with IPV, and finally, conduct a pilot trial of the FCC model to assess its acceptability and feasibility.